TEM, CONFOCAL STRUCT: CYTOKINESIS &CELL TO CELL INTERACT IN PLANT LIKE PROTISTS

Application of immune fluorescence and ultrastructural immunolocalization techniques to charophycean algae is expected to illuminate fundamental aspects of cytokinesis and intercellular communication of importance in higher plant morphogenesis and embryogenesis.